PRESCIENT: A phase IIc, open-label, randomized controlled trial of ultra-short course bedaquiline, clofazimine, pyrazinamide and delamanid versus standard therapy for drug-susceptible tuberculosis

PROJECT SUMMARY/ABSTRACT
Standard first-line therapy for drug-susceptible tuberculosis (DS-TB) is highly effective but complicated by long
treatment duration and rifamycin drug-drug interactions, particularly with antiretroviral therapy (ART) in high HIV-
TB burden countries. A well-tolerated and efficacious rifamycin-free regimen that can shorten TB treatment
duration is critically needed to achieve World Health Organization (WHO) targets towards ending TB. Our group
pioneered the use of an artificial-intelligence-enabled parabolic response surface (PRS) platform allowing rapid
identification of the most effective drug-dose combinations by testing only a small fraction of the total drug-dose
efficacy response surface. This approach determined that drug combinations including bedaquiline (BDQ),
clofazimine (CFZ), and pyrazinamide (PZA) at optimal dose ratios were more effective than standard DS-TB
treatment, achieving relapse-free cure in mouse models within 3-4 weeks. Adding delamanid (DLM) as a 4th drug
was equivalent in potency, achieving 100% relapse-free cure in only 3 weeks. This is substantially shorter than
time to relapse-free cure in mouse studies supporting other TB treatment shortening trials. Bactericidal and
sterilizing ability confirmed in other experiments, and favorable intra-lesional pharmacokinetics (PK), provides
additional justification for evaluation of the BDQ-CFZ-PZA-DLM (BCZD) combination for treatment shortening.
This 8-week rifamycin-free ultrashort regimen fulfills key requirements of the WHO target regimen profile for DS-
TB: lower potential for drug-drug interactions, established tolerability and safety, constituent agents registered
and accessible, and optimized dosing based on clinical data. We hypothesize that BCZD will demonstrate
superior microbiologic efficacy relative to standard therapy during the first 8 weeks of treatment for patients with
DS-TB. To test this, we shall conduct a Phase IIc, open-label, randomized controlled trial to investigate the
efficacy and safety of an 8-week regimen of BCZD, paving the way for a definitive treatment-shortening trial and
potentially shifting clinical practice. Our trial, called PRESCIENT, will randomize 156 adults with smear-positive
DS-TB, with and without HIV, to receive BCZD for 8 weeks versus standard therapy for 26 weeks (1:1 ratio). The
primary objective is a superiority efficacy comparison of time to liquid culture conversion through 8 weeks; the
Phase IIc design also enables evaluation of clinical endpoints through extended post-treatment follow up to 56
weeks (Aim 1a - efficacy). Secondary objectives include rigorous assessment of safety and tolerability (Aim 1b
- safety), and drug susceptibility testing and whole genome sequencing to determine frequency of treatment-
emergent resistance to BCZD (Aim 1c - resistance). We shall also explore the effect of experimental drug
exposure, derived from population PK models, on time to culture positivity as a measure of mycobacterial burden
and treatment response, and on corrected QT interval (Aim 2 - PK/PD). PRESCIENT will be conducted at
established clinical research sites in Haiti and South Africa which have access to large populations of patients
with DS-TB and have the necessary expertise and infrastructure to successfully implement this project.

Public health relevance
PROJECT NARRATIVE Shorter, well-tolerated, and efficacious rifamycin-free regimens for the treatment of drug-susceptible tuberculosis (TB) are critically needed to attain the World Health Organization targets towards TB elimination. Using a novel artificial-intelligence-enabled parabolic response surface platform, we identified an experimental regimen comprising bedaquiline, clofazimine, pyrazinamide, and delamanid (BCZD), which achieved relapse- free cure in 3 weeks in mouse models. Based on this compelling pre-clinical data, and established safety profile of constituent drugs, we propose a Phase IIc, open-label, randomized controlled trial to investigate the efficacy and safety of an 8-week regimen of BCZD compared to standard therapy for drug-sensitive TB, paving the way for a definitive treatment-shortening trial and potentially shifting clinical practice.